Resilient Together-ALS (RT-ALS): A dyadic mind-body meaning intervention for people with ALS and their informal care-partners

PROJECT SUMMARY
Background: Approximately 31,000 patients in the United States and 500,000 people worldwide are living with
Amyotrophic Lateral Sclerosis (ALS), an uncurable, progressive neurodegenerative disease (NDD) that affects spinal cord
and brain nerve cells leading to loss of motor control, difficulty swallowing, paralyses, respiratory failure, and death
within 3-5 years. Half of patients with ALS experience clinically significant emotional distress at diagnosis and patient
and care-partner distress are strongly related (i.e., dyad); if untreated, this early distress can become chronic. No routine
treatment exists for addressing emotional distress in ALS dyads early after diagnosis. Specific Aims and Design: My
K23 aims to develop, refine, and pilot a mind-body meaning intervention to prevent chronic emotional distress: “Resilient
Together ALS (RT-ALS).” My aims are guided by the NCCIH Research Framework. Aim 1: Develop RT-ALS. I will
conduct 1) qualitative semi-structured interviews (about 20 dyads or until saturation) to gather feedback on intervention
content and delivery preferences; and 2) focus groups (3-4; about 20 staff total until saturation) with interdisciplinary ALS
providers to gather feedback on session content and barriers and facilitators to recruitment. Aim 2: Optimize RT-ALS. I
will explore initial feasibility and acceptability of RT-ALS via a single-arm open pilot (N=10 dyads) with exit interviews
and pre-post assessments. Aim 3: Test the feasibility and acceptability of the refined RT-ALS intervention. I will conduct
a pilot feasibility randomized clinical trial (RCT) of RT-ALS vs. minimally enhanced usual care (MEUC; educational
pamphlet) (N=50 dyads). Findings from this K23 proposal will inform a multisite feasibility R01 trial followed by a
multisite efficacy trial using the UH3/UG3 mechanism and subsequent implementation and dissemination (NCCIH
Research Framework). Training and Mentoring: To pursue the proposed research, I have 3 training aims: 1) Qualitative
methods for intervention development and optimization; 2) Mixed methods for intervention development and
optimization; and 3) Dyadic mind-body meaning RCT methodology. This research and my training will be supported by
my exceptional mentoring team with expertise in mind-body dyadic intervention development (Vranceanu), spirituality
and meaning (Park), ALS (Lindenberger, Brizzi), and statistics (Parker). Further, I have access to a rich institutional
environment as well as coursework, scientific meetings, trainings, and planned publications tailored to training aims and
the proposed research. Relevance to NCCIH: The proposed research aligns with the NCCIH Strategic Plan FY 2021–
⁠2025 Objective 2: Advance research on the whole person and on the integration of complementary and conventnioal care;
and Objective 3: Foster research on health promotion and restoration, resilience, disease prevention, and symptom
management. Impact: My goal is to become a clinical investigator who builds dyadic mind-body meaning interventions
in ALS/NDDs. If funded, the K23 would support the training, mentorship, partnerships, and research experience I need to
transition to independence. If successful, findings from this K23 proposal will inform a multisite feasibility R01 trial
followed by a multisite efficacy trial using the UH3/UG3 mechanism and subsequent implementation and dissemination
(NCCIH Research Framework). The proposed research has the potential to reduce suffering and disease burden for
patients with ALS, their care-partners, and the healthcare system. Future work could explore dissemination and
implementation in settings nationally and worldwide adapted to a range of serious illnesses and local cultural context.

Public health relevance
Project Narrative Approximately half of patients with ALS and their care-partners experience emotional distress early after diagnosis, and distress is linked with illness progression and dyadic functioning. Resilient Together-ALS (RT-ALS) is a dyadic, mind- body meaning intervention to address emotional distress in ALS dyads early after diagnosis. RT-ALS has the potential to address the gap in mind-body psychosocial care for dyads experiencing ALS with potential future adaptation in clinics worldwide.